Analysis of Cellular Plasticity in White Adipose Tissue.

ABSTRACT
The long-term goal of this project is to understand the cellular and molecular mechanisms of adipose tissue
establishment, maintenance, and pathophysiological remodeling. Our central hypothesis is that adipose tissue
plasticity involves the creation and resolution of dynamic adipogenic niches involving close interactions among
specific stromal and immune cell subtypes. While single cell RNA sequencing (scRNA-seq) has identified the
stromal and immune phenotypes that are involved in adipose tissue neogenesis, how these cells are recruited
to specific locations and interact to create and resolve adipogenic niches has not been addressed. In this
continuation we will use cutting edge high-dimension, high-resolution spatial transcriptomics and proteomics to
map, order, and test the cellular events underlying adipose tissue neogenesis.
Despite recent advances in single cell profiling, the origins of adipocytes and lineage relationships of stromal
cells in adipose tissues remains controversial. To address this critical gap in knowledge we will apply newly-
developed CRISPR/Cas9-based technologies for unbiased, high-dimension resolution of cell lineages during
the life cycle of adipose tissues. This technology will be integrated with complementary techniques of spatial
transcriptomics, multiplexed 3-dimensional single molecule fluorescence in situ hybridization and
immunofluorescence. This integrated approach will provide comprehensive, unbiased spatial analysis of
lineage relationships in postnatal adipose tissue establishment, expansion, aging, and remodeling in vivo.
Successful completion of this proposal will provide the first unbiased high-dimension, single-cell resolution map
of mouse adipose tissues during establishment, expansion, and aging. We will determine the cellular and
molecular mechanisms of adipogenic niche formation and resolution, and resolve long-standing questions of
cell lineages in a comprehensive and unbiased fashion.

Public health relevance
NARRATIVE The proper function of adipose tissue is essential for metabolic health and depends on close interactions of diverse cell types in the tissue microenvironment. This project will examine how close (micrometer-scale) cellular interactions in adipose tissue regulate the establishment, expansion, and pathophysiological remodeling fat tissues. This analysis will provide new insights into how fat tissue contributes to metabolic heath, and might lead to strategies to combat obesity-related metabolic diseases like diabetes.